A Bioluminescent Assay for Direct Measurement of Sirtuin Activity in Cancer Cells

A bioluminescent assay for direct measurement of sirtuin activity in cancer cells
Sirtuins are nicotinamide adenine dinucleotide (NAD+)-dependent lysine deacylases that act on histones,
transcription factors, epigenetic regulators and metabolic enzymes to regulate key cellular functions such as
apoptosis, senescence and energy metabolism. Depending on the cellular context, sirtuins can promote or inhibit
oncogenesis, defining a critical need for methods capable of interrogating sirtuin activity in intact cells and animal
models. However currently available sirtuin assays are confined to cell free systems, are prone to artifacts, and
have limited sensitivity and dynamic range. The lack of assays that provide a reliable, direct and real-time readout
of sirtuin activity in vitro and in vivo poses a major barrier to drug development and biological studies.
To overcome the limitations of current assays we propose luciferase-based assay that reports in real-
time sirtuin activity in cell free and cellular assays through generation of a bioluminescence signal by conversion
of furimazine to furimamide. Our design is based on a split-NanoLuc complementation system that consists of a
truncated catalytically inactive N-terminal moiety (termed 11S), which is activated by complementation with a
high affinity 11-aa C-terminal peptide containing two lysine residues (K8,K9). Our premise is that acylation or
other modifications of the lysine residues within the high affinity C-terminal complementation peptide inhibit its
binding to the N-terminal NanoLuc moiety, preventing activation; active sirtuin enzyme removes the acyl groups,
allowing for luciferase complementation and generation of a luminescence signal. Our preliminary data using
SIRT5 enzyme demonstrate a robust reporter signal in cell free assays, and suggest that measurement of
intracellular sirtuin activity is feasible. In Aim 1 we will adapt the split-NanoLuc assay for measuring sirtuin
deacylase activity in cell free systems and determine which lysine modifications within the C-terminal
complementation peptide block binding to the large NanoLuc fragment, and are removed by sirtuins 1 – 7. We
will optimize assay conditions, and delineate performance parameters (sensitivity, selectivity, dynamic range,
coefficient of variation). In Aim 2 we will adapt the split-NanoLuc assay for measurement of SIRT5 activity in live
cells and in vivo. We will generate SIRT5 reporter cell lines, targeting the truncated NanoLuc to specific cellular
compartments. We will optimize conditions for quantitative bioluminescence measurement in live cancer cells
and in vivo, using CRISPR/Cas9, shRNA and inhibitors to modulate SIRT5 activity. Our design has critical
advantages over current approaches: (i) Potential adaptability to any type of acyl modification; (ii) High signal-
to-background ratio; (iii) Avoidance of artifact-prone chemically modified probes; (iv) Adaptability to
measurement of enzyme activity in live cells and animal models. Successful completion of this project will result
in the establishment of a versatile and sensitive assay for detection of sirtuin deacylase enzymatic activity in cell
free systems, live cancer cells and animal models of cancer, overcoming a major barrier in the field.

Public health relevance
PROJECT NARRATIVE Sirtuins are a family of seven distinct protein lysine deacylases that regulate key cellular functions and promote or suppress oncogenesis, depending on the cellular context. Despite being implicated in multiple malignancies, solid and hematopoietic, no sirtuin inhibitors have been approved for use in humans, and the drug discovery process is hampered by the fact that existing sirtuin activity assays: (i) exhibit limited dynamic range and sensitivity, (ii) are prone to artifacts that prevent interpretation of results from large screens, and (iii) are not amenable to in vivo imaging. We propose to engineer a split-luciferase based system for precise, sensitive and versatile measurement of sirtuin activity in vitro and in vivo, removing a major barrier to understanding sirtuin biology in cancer and to developing potent and selective sirtuin modulators.